Protein structure determination from low-resolution experimental data

Abstract
Determination of a protein’s three-dimensional structure is of critical importance in biology,
providing insights to biological mechanisms and important targets for drug design. While high-
resolution X-ray diffraction data provides an atomic view of cellular components, for many
interesting and biologically relevant complexes, it may only be possible to obtain low-resolution
structural information. In recent years, cryo-electron microscopy (cryo-EM) has emerged as a
powerful method to gain structural insights into these large molecular machines. However, for
many complexes of interest, data is often: a) extremely limited in resolution, lacking atomic
details, and b) highly heterogeneous in terms of data quality. Both effects are due to the
inherent flexibility of many of these complexes. Extracting detailed atomic information from this
data, critical in understanding function, the effects of mutation, or in designing drugs is
impossible due to the low number of observations and the large conformational space proteins
may adopt. We propose a suite of computational methods for inferring high-accuracy atomic
models from this low-resolution data, revealing detailed structural insights into these complexes.
In the previous granting period, we: a) developed a set of tools for accurately building and
refining protein models into low-resolution experimental cryoEM maps, b) released these tools
as freely available software and gave tutorials to enable cryo-electron microscopists to use
these methods, and c) closely collaborated with dozens of microscopists to develop custom
methodology for their particular systems of interest. In this proposal, we further these methods
in several distinct directions. We develop methodology for accurately identifying ligands and
accurately modelling ligand conformations in low-resolution datasets. We build off of machine-
learning-guided protein structure prediction, and develop methods to more rapidly and robustly
interpret low-resolution cryo-EM datasets. We feel these methods should be fast enough to be
suitable for use in an on-line data processing pipeline. Finally, we develop methodology to
untangle structural heterogeneity by building a heterogeneous set of protein models that best
explains variations in single-particle images, providing structural insights into the conformational
heterogeneity of single-particle data.
The overall goal of the proposed research is robust and accessible methods to interpret – to the
level of atomic accuracy – low-resolution and heterogeneous cryo-EM datasets. Combined, the
three aims in this proposal will lead to dramatic improvements in our ability to infer atomic
interactions from such datasets. As microscopists continue tackling more complicated protein
complexes, these methods will be needed to reveal atom-level insights into how biomedically
important protein complexes perform their function and what goes wrong in human disease.

Public health relevance
Project Narrative This project develops computational tools for automatically and accurately determining atomic structure from low-resolution cryo-electron microscopy data. The proposed work will lead to dramatic improvements in our ability to model dynamic structures of protein complexes. Obtaining accurate structures from this data will reveal insights into the workings of biomedically important protein complexes, and what goes wrong in human disease.